tDCS Augmentation of Cognitive Remediation in Schizophrenia

DESCRIPTION (provided by applicant): This project evaluates the efficacy of combined transcranial direct current stimulation (tDCS) and auditory neuroplasticity based remediation in Schizophrenia (Sz). Auditory dysfunction is a core feature of Sz and contributes to impairments in emotion recognition, verbal working memory, reading and social cognition. Prior studies of auditory remediation have demonstrated improvements in cognition, in combination with indices of improved neuroplasticity. tDCS is a newly developed brain stimulation modality that enhances local neuroplasticity across brain regions. To date it has been used primarily for stroke rehabilitation. This will be the first study of efficacy for augmentation of cognitive remediation n Sz. We have recently demonstrated that tDCS significantly enhances concomitant event-related potential (ERP) generation when applied during learning situations, permitting direct assay of target engagement. For the present study, ERP will be used to monitor target engagement and treatment efficacy. The project is responsive to the RFA (PAR 11-177) in the following ways: 1) This represents a biologically informed, novel and highly innovative approach to alter a functional treatment target (auditory dysfunction) which is relevant to functional outcome in Sz; 2) brain stimulation (tDCS) will be conducted using an IDE-approved device in combination with a previously validated behavioral intervention; and 3) proof-of-principle for the combination approach is required prior to initiation of an RCT. Assessments will assess impact of the intervention at multiple levels (behavioral, neurochemical, neurophysiological). The R21 phase is necessary to pilot the interventions. The R33 phase is designed to pilot the interventions and demonstrate feasibility of recruitment, retention, assessment procedures and safety, and to obtain an initial assessment of effect-size for use in planning a future, definitive trial. No inferential statistics are proposed. Although the present study focuses on persistent auditory deficits in chronic Sz patients, investigation of tDCS efficacy in enhancement of neuroplasticity will be relevant across a range of disorders and neurocognitive constructs.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cognitive dysfunction is a core feature of schizophrenia and a primary predictor of poor long term outcome, such that deficits in basic auditory function contribute to impairments in higher order functions such as auditory emotion recognition, verbal working memory, and social function. Transcranial direct current stimulation (tDCS) is a recently developed brain stimulation modality that increases the ability of the brain to learn new information and respond to training exercises ("plasticity"). This study will assess the ability of tDCS to enhance the effectiveness of auditory remediation in schizophrenia, as well as the ability of auditory retraining to improve overall aspects of cognitive function in schizophrenia. __SpecificAimsTextDelimiter__ 2. Specific aims Schizophrenia (Sz) is associated with persistent neurocognitive deficits that constrain psychosocial achievement. Cognitive remediation approaches, while promising, are limited by the relatively large "dosing" that is required, the limited number of functions that can be targeted and the degree of recovery obtained. Transcranial direct current stimulation (tDCS) is a recently developed, well tolerated brain stimulation approach that may augment brain plasticity when paired with motor, sensory or cognitive remediation. This study assesses efficacy of tDCS for augmentation of neuroplasticity-based auditory remediation (AR) in Sz. In Sz, deficits are observed across multiple neurocognitive domains. In the auditory system, deficits include reduced tone matching ability, which contributes to impairments in higher cognitive functions such as auditory emotion recognition (AER), verbal learning, and reading. AR partially ameliorates these deficits, although ideal physical features to be remediated remains to be determined. In tDCS, low currents ( 2 mA) are applied over specific brain regions to modulate local cortical plasticity. In general, anodal currents enhance activity relative to sham or cathodal stimulation. tDCS effects are mediated at least in part via modulation of local NMDAR function and stimulation of BDNF secretion. Use of tDCS is thus consistent with current glutamatergic theories of Sz. In this study, tDCS over auditory cortex will be paired with auditory-based remediation. Event-related potentials (ERP) and behavioral measures will be used to assess efficacy and target engagement. The project will proceed in two phases. First, we will establish optimal parameters for auditory stimulation and tDCS. Second, we will conduct a randomized, parallel group pilot study of combined tDCS and AR vs. sham stimulation/active AR vs. visuomotor control to evaluate feasibility and promise of the intervention. This is the first clinical study to use ERP monitoring of tDCS effects and the first to investigate tDCS effects on cognitive remediation in Sz. Results will be relevant not only to AR in Sz, but also to use of tDCS to augment remediation across neurocognitive disorders and domains, and use of ERP to monitor tDCS effects. Specific aims: R21 phase (years 1-2) 1. To verify critical auditory features for targeted remediation. Neuroplasticity-based AR has been conducted using brief, high frequency FM glides. However, patients show deficits as well in ability to differentiate base tonal frequencies (F0M) and depth of modulation (F0SD) of simple FM tones. Deficits in F0M and F0SD detection correlate with deficits in AER. In year 1, we will evaluate specific auditory features that are most tied to higher auditory deficits in Sz with the goal of prioritizing features for intervention. 2. To determine optimal placement of auditory tDCS for enhancement of auditory function. The ability of tDCS to modulate auditory function has been investigated in studies of tinnitus and auditory perception, but ideal electrode placement for enhancement of auditory function is not known. In preliminary studies, we have demonstrated that tDCS-induced enhancement of plasticity is associated with modulation of ERP activity. In year 1, we will use ERP as target engagement markers to optimize tDCS configuration. 3. To verify within-session auditory plasticity: Remediation in Sz is limited by lack of neuroplasticity. During year 2, we will verify that protocols developed in year 1 lead to enhanced auditory plasticity and ERP modulation within individual training sessions as a criterion for initiation of the double blind R33 study. Specific aims: R33 phase (years 3-5) 1. To evaluate effects of tDCS-enhanced Auditory Remediatoin (AR) on specific measures of auditory function. Patients will receive 50-60 hrs of AR over 4-6 mo. Pre/post auditory function will be assessed using behavioral (tone matching) and neurophysiological (auditory N1, MMN, ASSR) measures. Plasma D-serine and BDNF levels will be evaluated as potential mediators of response. 2. To evaluate effects of tDCS-enhanced auditory remediation (AR) on emotion processing, verbal learning, neurocognition, and social occupational function. Neurocognition measures will include MCCB, ER40, CTOPP and neurophysiological measures related to general cognition (e.g. auditory P300). Social/occupational function scales will include GAF, ILS-PB, UPSA-B, SSPA, and SLOF. In addition, TEPS, IMI, PCS and TMQ scales will be used to assess target engagement. Overall, these studies will assess safety and tolerability of tDCS as an adjunct to cognitive remediation, and will serve as a pilot study to determine whether future, definitive clinical trials are warranted.